Cellular and network mechanisms of epilepsy and neuromodulation

Cellular and network mechanisms of epilepsy and neuromodulation
Summary
Epilepsy is the world’s most common, serious brain disorder, affecting nearly 50 million people worldwide, and
accounting for 1% of the global burden of disease. Seizures occur sporadically and paroxysmally in epilepsy and
several interictal biomarkers that are present between seizures have been identified to aid in management. Three
major interictal biomarkers for seizure risk have been identified, including epileptiform discharges (spikes), high-
frequency oscillations (ripples) and their co-occurrence known as spike ripples. We and others have
demonstrated that spike ripples in human scalp EEG and stereotactically placed intracranial EEG recordings are
the most specific biomarkers to isolate epileptogenic cortex and predict seizure risk. While clinically significant,
the neural mechanisms of this epilepsy biomarker remains unknown, and its relationship to seizure generation
is unclear. Further, neuromodulation through electrical stimulation is a rapidly expanding and promising
treatment option for patients with drug-resistant refractory epilepsy, but the lack of understanding of the neuronal
mechanisms has prevented a principled approach in identifying optimal stimulation parameters for consistent
clinical response. To address these challenges, we formed an interdisciplinary team with expertise in epilepsy,
human neurophysiology, neurostimulation, animal experiments, modeling, and statistics. We will use cutting-
edge cellular membrane voltage imaging that we recently pioneered, in conjunction with traditional optogenetics
and local field potential recordings, to probe the cellular and network mechanisms of spike ripples and seizures
in cortical epilepsy mouse models. Further, we will examine the real-time neuronal impact of clinical electrical
stimulation parameters across frequencies and durations on this epilepsy biomarker and seizure, using cellular
voltage imaging, free of electrical stimulation artifacts, and compare the impact of stimulation delivered locally at
the cortical epileptogenic zone versus at a thalamic “hub” within the epileptic network. At the completion of the
study, we hope to elucidate the neuronal mechanisms underlying epileptic activity, reveal insights on how spike
ripples relate to seizure, and gain progress towards a principled approach to neurostimulation with an ultimate
goal of improving care for patients with epilepsy.

Public health relevance
Project Narrative Epilepsy is the world’s most common, serious brain disorder, affecting nearly 50 million people worldwide, and accounting for 1% of the global burden of disease. Seizures occur sporadically and paroxysmally in epilepsy and several interictal biomarkers that are present between seizures have been identified to aid in management. This study aims to examine the cellular and network mechanisms of epilepsy interictal biomarkers and the therapeutic mechanisms of electrical stimulation using cutting edge cellular voltage imaging and optogenetics techniques.